Cancer Control Program

PROJECT SUMMARY – Cancer Control Program
The Cancer Control Program (CCP) is a highly collaborative and transdisciplinary Program that focuses on
identifying and analyzing the genetic, behavioral, and health care determinants of cancer susceptibility and
outcomes in diverse and vulnerable populations and on developing, evaluating and implementing interventions
to lower risk and improve cancer outcomes. CCP is one of two Population Science Research Programs of the
Abramson Cancer Center (ACC). CCP has 39 members who work intra- and inter-Programmatically to apply
advances in science to population health and cutting-edge data analytics, address the cancer burdens and risk
factors in our catchment area, and train the next generation of cancer control researchers. Members conduct
research within four broad and interconnected Program aims: 1) Cancer Genomics and Risk; 2)
Communication and Health Behavior; 3) Cancer Survivorship; and 4) Health Care Outcomes. CCP has
produced a substantial body of high impact work in the current funding period. In Cancer Genomics and Risk,
members have established the basis for clinical management of individuals with moderate penetrance risk
genes for breast and colorectal cancer, identified risk loci associated with susceptibility to testicular germ cell
tumors, and established the comparable efficacy of genetic counseling delivered through telehealth. In
Communication and Health Behavior, members have conducted innovative studies on the use of incentives for
improving early detection and novel transdisciplinary research in diet, obesity and cancer. In Cancer
Survivorship, members have established clinical paradigms for cancer survivors through patient-centered care
plans and have revealed important complexities in end of life care. In Health Outcomes, members have
innovated methods to use the electronic health record to improve health behaviors and have conducted
pragmatic trials to innovate new models of high-quality cancer care. CCP recruited 17 new members during the
current funding period in the areas of epidemiology, genomics, biostatistics, informatics, nutrition and the
microbiome. CCP works closely with the Tobacco and Environmental Carcinogenesis Program to create a
robust population science presence at the ACC. CCP members come from ten departments in the Perelman
School of Medicine, School of Nursing, Wharton School of Business, and Annenberg School for
Communication. There have been 640 cancer-related publications over the current funding period (13% intra-
Programmatic, 35% inter-Programmatic, 76% multi-institutional). Members have 30 R01-equivalents, $14.5M
(direct) in annual cancer-related research funding, of which $11.6M is peer-reviewed and $3.8M is from NCI.
During the funding period, CCP members enrolled 10,768 subjects onto interventional trials (with 819 onto
treatment trials) and 2,923 subjects onto non-interventional trials. In sum, CCP is a vibrant community of
interactive population science investigators working across four inter-connected aims to further research
impacting our catchment area and beyond.